NH PHL Discipline B Chemistry Analytical Track 1 - food defense

Discipline B: Chemistry Analytical Track 1: Food Defense To ensure laboratory surge capacity in the analyses of foods and food products for analyses related to chemical contamination, through intentional means, the NH PHL plans to: 1. Participate in FDA-requested annual triage exercises, and/or surveillance activities to support and maintain readiness. 2. Participate in national security event exercises, as available. 3. Maintain preparedness to rapidly respond to a suspected or confirmed intentional contamination event involving human or animal food. This includes ensuring analysts are trained and have passed competency exercises, equipment is in working order, and reagents and supplies are available. 4. Participate in testing associated with suspected or credible threats to the food supply where a chemical agent is suspected, as requested by FDA The NH PHL maintains readiness and ability to detect chemical contamination in vegetables and fruits (fresh and packaged); juices (concentrate and diluted); grains and grain products; seafood and other fish products; milk and other dairy products; infant formula; baby foods; bottled water; condiments; and alcoholic products (beer, wine, scotch). NH PHL will participate and pass annual proficiency tests, attend the LFFM Face-to-Face meeting and monthly calls, maintain ISO 17025 accreditation of CHE.0009 and other methods that fall under our accreditation, maintain facilities and personnel necessary to complete the work proposed, and provide a detailed quarterly summary of all samples collected and analyzed. The NH PHL will maintain a valid 20.88 agreement with the FDA.

Public health relevance
Project Narrative - Discipline B: Chemistry - Analytical Track 1: Food Defense The New Hampshire Public Health Laboratories (NH PHL) will support laboratory surge capacity for the analysis of foods and food products related to intentional chemical contamination. The activities of the NH PHL will enhance the Food Emergency Response Laboratory Network capacity and readiness to provide testing for poisons/toxins, toxic metals, and other contamination to support a fully integrated food safety system.